Dissecting the genetic underpinnings of heterochrony in limb bud initiation

ABSTRACT
The overarching goal of this project is to understand how timing is controlled during embryonic
development and to identify the molecular changes that led to changes in timing, or heterochrony, through
evolution. In particular, we will focus on the control of the time when the limb buds start to form in the embryo.
The relative timing of initiation of the fore and hind limb buds differs dramatically between birds (2-hour
differential in chicks) and mammals (18-hour difference in mice). In simplest terms, the hind limb forms at a
relatively later time in mice. We will attempt to understand this heterochrony on two levels:
Aim 1 will address the cis-regulatory landscape regulating timing of gene activity driving limb bud
initiation. Tbx4 is a transcription factor required for limb bud initiation, whose timing of expression closely
matches the time at which the hind limb starts to form in both chick and mouse. Using regulation of Tbx4 as a
starting point, putative enhancers have been identified in preliminary experiments that appear to drive proper
temporal expression of this gene in mouse and chick. Enhancer swap experiments between these species will
validate the contribution of these putative activating enhancers to timing of Tbx4 expression in the forming
limbs. In parallel, we will map potential inhibitory cis-regulatory sequences at the Tbx4 locus using a “silence
reporter” assay, and through loss of function experiments in mice.
In a complementary set of experiments, Aim 2 will focus on identifying transcription factors mediating
the relative delay in hindlimb initiation in mice. A list of candidate factors will be assembled from a comparative
analysis of scRNA-Seq data on cells taken from mouse and chick fore and hind limb domains, just prior to and
just after limb bud initiation. Candidates will be tested functionally through electroporation in developing chick
limb field. cRel, a candidate identified in preliminary studies, will be further tested functionally in the mouse.
As noted above, the timing of Tbx4 expression correlates well with the timing of hind limb bud initiation
in both chick and mouse. Moreover, preliminary data suggest that at least part of the timing of this gene’s
activity is established through regulation by the NFKB family member cRel. Interestingly, NFKB activity is
regulated by oxygen levels in other settings, and our preliminary data indicates that this is the case for cRel in
the limb bud. Accordingly, Aim 3 will dissect the regulatory relationship between oxygen levels and Tbx4
expression in the limb bud.
Together, the proposed studies will break new ground towards understanding the important, but under-
studied problem of timing during development, and the timing of limb bud initiation in particular.

Public health relevance
NARRATIVE Embryonic development requires that an exceedingly complex series of steps occur in the proper sequence, in the correct location and at the right time. This study will shed light on the timing of embryonic events, in particular how the formation of the limbs is controlled such that they emerge at the right time during gestation. This work will give new insights into the problems that can arise leading to birth defects such as amelia (congenital absence of limbs).